Gluconeogenic control of Dravet Syndrome

The goal of this administrative supplement is to request the purchase of a critical instrument (Seahorse XF24e,
Agilent Technologies) which is necessary for the continuation and completion of the project. To achieve the
major aims and goals of the parent project are to study metabolic defects in a devastating neurodevelopmental
disease known as Dravet Syndrome. A key assay that we have developed for this project is assessment of
metabolic defects in a zebrafish model of the disease. The assay involves the use of an extracellular flux analyzer
that measures mitochondrial and glycolytic functions in real time in live zebrafish larvae. The instrument is
requested to replace a new version of a previous model which has been retired by the company.

Public health relevance
The proposed research will provide novel insight into malfunction of energy producing pathways in pediatric genetic epilepsy and suggest innovative metabolic treatments for controlling pediatric seizures and behavioral impairment.